Symptom Biology After Heart Failure Hospitalization

PROJECT SUMMARY
The purpose of this Mentored Patient-Oriented Research Career Development Award (K23) application
is to provide additional research training for Dr. Jonathan Auld, a post-doctoral fellow at the University of
Washington School of Nursing. The long-term goals of the applicant are to independently lead an
interdisciplinary team in biobehavioral research and to design R-series studies that guide tailored HF symptom
management interventions using biological, behavioral and clinical data. Heart failure is a growing
cardiovascular disorder that is characterize by high symptom burden, poor quality of life and high healthcare
utilization. In addition, patients often struggle to identify and manage symptoms. A better understanding of how
symptoms change after patients are discharged and the biological underpinnings of HF symptoms will provide
needed information to address symptom burden earlier and to tailor symptom management intervention to
improve quality of life and healthcare utilization.
This career development award will support the applicant’s training and research goals through the
provision of mentorship, coursework, and other training activities directly relevant to the content areas of
advanced training in collection, measurement and analysis of HF biomarkers, symptom management
interventions for people with chronic HF, the use of novel remote monitoring technology, and career
development. The research project proposed in this application will examine how and when HF symptoms
change after hospitalization. The applicant proposes a prospective longitudinal study (n=60) of adults with
advance HF (NYHA III) after discharge from a HF hospitalization. Importantly, we will use novel data from
CardioMEMS devices to better understand HF symptom biology. Specifically, this study aims to: 1)
characterize and compare patterns of change in physical and psychological symptoms (dyspnea, fatigue, pain,
depression and anxiety) biomarkers (IL-6, TNFα, NT-proBNP, sST2 and Galectin-3) and health-related quality
of life over 6 months (discharge, 1 month, 3 months, 6 months) in patients with CardioMEMS and without
CardioMEMS, 2) characterize and compare healthcare utilization over 6 months (medication changes, nurse
phone contacts, urgent clinic visits, emergency room visits, re-hospitalizations, and mortality) in the
CardioMEMS and non-CardioMEMS groups, and 3) quantify the association between CardioMEMS pulmonary
artery pressure data, HF biomarkers, physical and psychological symptoms and HRQOL over 6 months.
Descriptive statistics, latent growth curve modeling, parallel process growth curve modeling, and multivariate
generalized linear modeling will be used to compare and characterize HF symptom trajectories, biomarker
trajectories, and predictors of healthcare utilization over 6 months after discharge. Both the short and long-term
goals of this Career Development Award align with the strategic mission of The National Institute of Nursing
Research to understand the biological mechanisms of HF symptoms.

Public health relevance
PROJECT NARRATIVE Heart failure (HF) is the fastest growing cardiovascular disorder, affecting 6.5 million people in the United States and over 30 million worldwide. Heart failure is the leading cause of hospitalization in adults over 65 years of age and is characterized by heavy symptom burden and poor quality of life. A more complete understanding of how symptoms change after hospital discharge and the biological mechanisms associated with these changes will guide targeted interventions to more effectively address symptoms burden, quality of life and healthcare utilization.